Genomics and Genomic Analysis Core

PROJECT SUMMARY/ABSTRACT
The purpose of the Genomics Core is to provide instrumentation, computational infrastructure, technical and
analytic expertise, and guidance in order to broadly enable and to enhance the use of genomic analysis in Cystic
Fibrosis (CF) research. Among other areas of research focus, the Genomics Core places a special emphasis in
understanding of the microbiology and molecular physiology of people with CF (PWCF) in the post-CFTR
modulator era. The Aims of the Core are to: 1) Provide advanced services to understand gene expression and
molecular physiology of human cells that are relevant to CF disease states, 2) Provide cutting-edge
sequencing and computational resources to study microbial communities in the CF gut, 3) Provide cutting-
edge sequencing and computational resources that advance research on microbes and host-microbe
interactions associated with CF disease states, and 4) Develop and support novel technologies to advance
genomic research in CF.
These aims will be fulfilled by providing UW CF researchers with consultative, production, and analytical
services relevant to the following domains:
1. Transcriptome sequencing (conventional and single cell RNA-Seq) and targeted gene expression
analysis (qRT-PCR).
2. Microbiome analysis through 16S rRNA profiling, taxon-specific qPCR, droplet digital PCR, and
metagenomic sequencing.
3. DNA sequencing of microbes for whole genome analysis, genetic variant identification, and variant
interpretation.
4. Genome-scale genetic screens using transposon mutant sequencing (Tn-Seq) and defined transposon
mutant libraries.
5. New sequencing technology innovation.
6. Data analysis, management, and integration, including consultation on interpretation of genomic data and
training in genomic methods.
These capabilities will help illuminate the mechanisms and pathophysiology of extrapulmonary and
respiratory CF diseases, informing novel strategies for the prevention, treatment, and diagnosis of those
illnesses. We also aim and to understand how the administration of highly effective CFTR modulators changes
the physiology of host cells, and the composition and metabolic functions of the microbiome and its interactions
with host individuals.